Characterization of structure-function relationships in distinct thalamic reticular nucleus networks

PROJECT SUMMARY
Nearly all sensory information destined for the neocortex is relayed through the thalamus. The thalamic
reticular nucleus (TRN), a thin shell of GABAergic neurons surrounding the dorsal thalamus, receives both
collaterals from cortico-thalamic and thalamo-cortical glutamatergic inputs, but exerts its unidirectional powerful
inhibition only to the thalamus. TRN thus is considered as a master controller of thalamo-cortical circuits
regulating the flow of the information between thalamus and neocortex. Perturbed TRN function may underlie
behavioral deficits in disorders ranging from schizophrenia, ADHD and autism. Although the importance of the
TRN has long been recognized, our knowledge of its molecular identity of cell types, their organization and
their functional properties has lagged behind that of the thalamocortical circuits they control. The paucity of
such knowledge has limited our ability to determine exactly how TRN circuitry contributes to various brain
functions, a prerequisite for determining how it malfunctions in diseases and how its circuitry can be leveraged
for diagnostic and therapeutic purposes. Our most recent work has filled this critical gap in knowledge. By
using single nucleus RNAseq, for the first time we have discovered that TRN neurons can be dissociated into
two major subtypes with distinct transcriptomic profiles, anatomical localizations, electrophysiological
properties and thalamic connectivity. One subtype, located in the “core” region of the TRN and can be marked
by the expression of the Spp1 gene, targets first-order sensory thalamic nuclei, and the other, located in the
“shell” region of the TRN and marked by the expression of Ecel1 gene, targets higher-order ones. We have
generated transgenic mice expressing Cre recombinase in each of these two populations individually. This
proposal aims to use these new knowledge and genetic tools to provide a comprehensive map of TRN cell-
type specific connectivity patterns, TRN subcircuit electrophysiological properties and synaptic mechanism,
and how abnormal function of distinct TRN subcircuits contribute to behavioral deficits of autism spectrum
disorder (ASD) using a novel monogenic form of ASD, Ptchd1 deletion mouse model.

Public health relevance
PROJECT NARRATIVE The thalamic reticular nucleus (TRN), the major source of thalamic inhibition, plays critical roles in regulating information passing between thalamus and neocortex. TRN dysfunction may underlie sensory abnormality, attention deficit and sleep disruption across multiple neurodevelopmental disorders. Despite its central importance, current understanding about how TRN neurons regulate such diverse functions is still limited. The current proposed work aims to investigate structure-function relationships in distinct TRN networks regulate behavioral processes in health and disease.